TRANSJUGULAR PORTASYSTEMIC SHUNTS/PARACENTESIS FOR TREATMENT OF ASCITES

To evaluate the effectiveness of Transjugular Intrahepatic Portasystemic Shunt for the treatment of refractory ascites compared to treatment with large volume paracentesis.